Training in Research on Addictions in Interdisciplinary NeuroAIDS (TRAIN)

DESCRIPTION (provided by applicant): Training in Research on Addictions in Interdisciplinary NeuroAIDS (TRAIN) Interdisciplinary clinical research on the combined effects of substance abuse and HIV infection on brain structure and function is of considerable relevance to public health initiatives. However, there are presently very few laboratories conducting such research and no current training programs dedicated to preparing the next generation of investigators in clinical research at the intersection of addictions and neuroAIDS. Accordingly, we propose to establish a new Ruth L. Kirschstein National Research Service Award Institutional Training Grant (NRSA T32) entitled, Training in Research on Addictions in Interdisciplinary NeuroAIDS (TRAIN). The aim of TRAIN is to prepare a steady state of four pre-doctoral students and two post-doctoral fellows in clinical neuropsychology for multidisciplinary academic careers focused on the central nervous system (CNS) effects of substance abuse and HIV infection. We will recruit a highly qualified and culturally diverse cohort of trainees that demonstrate promise toward achieving productive academic careers. The TRAIN program will emphasize research training in three primary, interrelated CNS outcomes, which were selected because of their salience and

Public health relevance
Substance abuse and HIV infection are highly prevalent, commonly co-occur, and have adverse affects on brain structure and function, but too few scientists are properly trained to study these important phenomena. Therefore, this new training program seeks to develop the next generation of academic leaders in this important area. To accomplish this goal, this program will recruit a diverse and promising cohort of pre- and post-doctoral trainees to engage in individualized, rigorous clinical research training in substance abuse and HIV under the mentorship of the accomplished, interdisciplinary faculty at the University of California, San Diego.